Gene-pesticide interactions and ADHD

Attention Deficit Hyperactivity Disorder (ADHD) is the most prevalent neurodevelopmental psychiatric disorder
(9.4% prevalence in children; 4.4% in adults) and is polygenic. A novel gene associated with ADHD is
Latrophilin-3 found in striatum, hippocampus, cerebellum, prefrontal cortex (PFC), and amygdala. In humans,
there are 21 variants of LPHN3 associated with ADHD. Some pesticides may interact with ADHD genetic risk
factors to trigger or exacerbate the symptoms. We found that the common pyrethroid, deltamethrin (DLM),
administered prior to weaning in rats causes long-term behavioral, neurochemical, and electrophysiological
effects. We developed the first KO rats of Lphn3. Lphn3 KO rats are hyperactive, hyper-reactive to startle
stimuli, and cognitively impaired. This PAR-19-386 “Environmental Risks for Psychiatric Disorders: Biological
Basis of Pathophysiology” seeks models that will elucidate Gene x Environment interactions related to
neuropsychiatric disorders, such as ADHD. We hypothesize that Lphn3-/- and Lphn3+/- rats will interact with
DLM (Type II pyrethroid) or permethrin (PRM, Type I pyrethroid) to exacerbate an ADHD-like phenotype.
Specific Aim 1: Determine the effects of DLM in Lphn3-/-, Lphn3+/-, and wildtype (WT) rats on activity,
reactivity, learning and memory (L&M), dopamine (DA) and NMDA markers, and apoptosis. Aim-1a: Compare
WT rats with Lphn3-/- and Lphn3+/- rats administered 0, 0.5, or 2.0 mg/kg DLM from P3-20 for changes in
activity, acoustic and tactile startle (including prepulse inhibition (PPI)) egocentric, allocentric, and working
L&M, and for changes in DA and NMDA-R markers in various brain regions, including markers for programmed
cell death. Aim-1b, neurochemical outcomes in rats not behaviorally tested. Specific Aim 2: Determine the
effects of PRM in Lphn3-/-, Lphn3+/- rats vs. WT rats on the outcomes used in Aim-1. Aim-2a: Same as Aim-1a
with PRM. Aim-2b: Same as Aim-1b with PRM. Specific Aim 3: Determine the effects of DLM in adult Lphn3-
/-, Lphn3+/- rats vs. WT rats. Aim-3a: same outcomes as in Aim-1a. Adults with ADHD are an understudied
and a population susceptible for higher exposure to pyrethroids from occupational exposure, making Aims 3
and 4 important. Aim-3b: Same as Aim-1b in adult rats. Specific Aim 4: Determine the effects of PRM in
adult Lphn3-/-, Lphn3+/- rats vs. WT rats. Aim-4a: Same outcomes used in Aim-1a. Aim-4b: Same as Aim-1b
in adult rats not behaviorally tested. Impact: ADHD interferes with normal development, costs billions to treat
and manage, yet we know little about environmental contributions to those with ADHD. Insecticides are
suspected in ADHD but such interactions between gene and environment are not established. Lphn3-/- and
Lphn3+/- rats represent a novel approach to probing the effects of exposure to pyrethroids using a known
ADHD genetic susceptibility. The model will shed new light on how a gene known to be associated with ADHD
affects the behavioral and biochemical effects of prototypical pyrethroids. Interaction data can be used for risk
assessment and help provide safeguards against pyrethroid exposure for those with ADHD.

Public health relevance
Attention Deficit Hyperactivity Disorder (ADHD) is the most prevalent psychiatric disorder, and a novel gene associated with ADHD is Latrophilin-3, however if environmental factors, such as pyrethroid exposure, interact with genetic factors to exacerbate this disorder is unknown. We developed a knock-out rat of Lphn3 that has abnormalities similar to ADHD (hyperactivity). We will test the combined effects of pyrethroids and Lphn3 knock-outs or heterozygous rats at different ages to elucidate whether this class of insecticides triggers or exacerbates ADHD-like effects in this model system.